Increasing the Capability and Capacity of Microbiological and Chemical Testing to Support an Integrated Food Defense and Food Safety System

Increasing the Capability and Capacity of
Microbiological and Chemical Testing to Support an
Integrated Food Defense and Food Safety System
Overall Component
Project Summary / Abstract
The Ohio Department of Agriculture (ODA) Consumer Protection Laboratory (CPL) and Animal
Disease Diagnostic Laboratory (ADDL) will strengthen the national food supply chain and
enhance federal and state regulatory effectiveness in food safety and defense, supporting the
Food Safety Modernization Act and the Food Emergency Response Network. The agency
proposes to participate in all US FDA initiated food defense activities related to animal or
human food including proficiency tests, surveillance activities, triage exercises, national security
event exercises and any other testing as requested by the FDA where suspected or credible
threats to the food supply are present. CPL will maintain operational readiness in supplies,
instrumentation and personnel should they be activated for a rapid response capable of testing
at least 50 microbiological and 75 chemical samples. ODA-CPL will also participate in state-
initiated product testing of human and animal food products, testing at minimum 2,000
samples total for microbiological and chemical contaminants. ODA-CPL will incorporate and
implement routine Cyclospora and allergen screening in human or animal food products. ODA-
ADDL will enhance the FDA’s GenomeTrakr network and the National Center for Biotechnology
Information’s Pathogen databases through Whole Genome Sequencing (WGS) and uploading of
at least 400 different human food, animal food or environmental isolates, providing support for
other state and federal partners and participating in any method validation studies as requested.
To improve communications with federal partners and minimize event response time, ODA-CPL
will enhance their existing data system, USALIMS, to integrate with the FDA ORA’s National
Food Safety Data Exchange. Lastly, ODA-CPL proposes to participate in a multi-laboratory
validation study of testing bottled water for metals by ICP-MS. Based on the current funding
opportunity, the agency requests $1,360,000 in project period 1 for samples, supplies, payroll,
services and equipment as needed to support all projects proposed and up to $5,060,000 in
additional funding as currently offered by FDA for the remaining project periods.

Public health relevance
Increasing the Capability and Capacity of Microbiological and Chemical Testing to Support an Integrated Food Defense and Food Safety System Overall Component Project Narrative Federal and state collaboration is essential to a secure national food supply, and the goals of increasing sampling numbers, contributing to the national genome and food safety databases and incorporating new or improved methods directly impact the effectiveness in fulfilling the mission of the Food Safety Modernization Act. Increased capability and capacity will improve state and federal incident response speed through faster testing turnaround times, improved interagency communications, more defensible data and provides for immediate regulatory action to prevent or reduce the scale of harm from any present or future event.